Development of the Inspired Therapeutics NeoMate Mechanical Circulatory Support System for Neonates and Infants

Project Summary/Abstract
Up to 14,000 children in the US are hospitalized with heart failure (HF)-related conditions each year with a
mortality rate of 7-15%. Heart transplant is the gold standard of therapy, but the mortality rate while on the
waiting list is 5-39%; thus, use of mechanical circulatory support (MCS) devices plays an important role in
supporting cardiovascular function in this challenging and heterogenous patient population. MCS options for
neonates and infants <10kg are especially limited, as their body habitus renders them too small to receive
implantable technology. The objective of this project is to complete development of the Inspired Therapeutics
NeoMate system designed to provide up to 30 days of MCS as an extracorporeal left ventricular assist device
(LVAD) for neonate and infant HF patients. The NeoMate system is comprised of a compact, miniature
centrifugal rotary pump, universal driver (controller with an embedded magnetically levitated (MagLev) motor),
and peripheral components (smart battery, touch-screen monitor). Building upon the successful development
of the prototype and feasibility testing (completed in SBIR phase I), the next two design iterations will be
completed in this SBIR phase II, including computational fluid dynamics (CFD) analyses to predict flow
dynamics and hemolysis risk (Aim 1), development of the NeoMate pump (Aim 1), and development of the
NeoMate integrated controller and motor with peripherals (Aim 2). The NeoMate system (2nd and 3rd design)
iterations will be tested in static and dynamic mock flow loops and acute and chronic ovine models to evaluate
hydrodynamic, hemodynamic, and hemocompatibility performance (Aim 3). Data will be used to refine the CFD
models and to iteratively improve the engineering design, fabrication, and performance of the NeoMate
system. Potential advantages of the NeoMate system include: (1) disposable low-cost pumps for short-term
MCS support; (2) reusable MagLev universal controller with integrated motor; (3) the platform technology may
support multiple future clinical cardiopulmonary indications for use; (4) smallest diameter impeller (27mm) and
compact, integrated, and miniature controller (51mm diameter, 115mm height, 681g weight). Completion of the
SBIR Phase II aims will enable Inspired Therapeutics to prepare for a phase IIB study to achieve design freeze
of the commercial clinical-grade NeoMate system in compliance with Good Manufacturing Practices, conduct
verification and validation testing, and complete the pre-clinical testing in compliance with Good Laboratory
Practices. Engineering control documents and experimental data will be used to support regulatory
submissions for approval to initiate a phase I clinical trial. The long-term goal of Inspired Therapeutics is to
build upon this platform technology to eventually expand the potential markets into cardiopulmonary bypass,
respiratory assist, extracorporeal membrane oxygenation, and bi- and right ventricular assistance; however, in
this SBIR phase II application, the NeoMate system is being developed and designed for left ventricular
assistance and in the underserved neonate and infant HF populations first.

Public health relevance
Project Narrative Heart transplantation is the standard therapy for the 14,000 children in the US hospitalized with heart failure (HF), but 5-39% of children will die while on the waiting list and there are not enough donor hearts available for every child that needs one. Because of this, doctors use mechanical heart devices as temporary support to help the child's failing heart but unfortunately device options are especially limited for neonates and infants as their body size is too small for current implantable devices. The objective of this project is to develop the Inspired Therapeutics NeoMate system that features a miniature, low-cost heart pump designed to provide up to 30 days of safe and effective cardiovascular support for neonate and infant HF patients with the goal of improving their quality of life while on device support and successfully bridging them to heart transplantation.